Using Neuroimaging to Investigate Mechanism-based Biomarkers of Schizophrenia

Project Summary/Abstract
Neuroimaging research has revolutionized our understanding of the biological factors that are contributing to
psychiatric illness, particularly schizophrenia (SZ). One of the most intriguing recent imaging findings in SZ is
an increased extracellular water volume (Free Water - FW), particularly in early phases of this disease. The
extracellular nature of FW increase suggests that it could be associated with extracellular matrix and/or blood
brain barrier (BBB) permeability. FW relationship with peripheral inflammation points to immunological brain
response. The biological nature of the FW increase in SZ, however, is still not clear.
In this application, we propose to investigate the neurobiological correlates of this phenomenon. Specifically,
we will utilize a novel, thoroughly validated animal model (Gclm knockout) in which oxidative stress and
neuroinflammation are mediated by a feedforward loop induced by matrix metalloproteinase 9 (MMP-9), and
test whether the phenotype associated with this model correlates with FW increase. We will characterize this
relationship in two ways - first, we will use large, already collected, multi-site and multi-modal patient data to
test for the relationship between neuroimaging, blood biomarkers, and cognition. Then, we will test this
relationship in a transgenic animal model using Gclm knockout mice and oxidative stress and MMP-9
modifiers.
We expect that upon successful completion of this project, we will have developed a clinically-feasible analytic
paradigm that will propose and validate novel noninvasive biomarkers to mechanistically link oxidative stress
and neuroinflammation to cognitive deficits observed in SZ. If successful, our proposal would potentially add a
new biological target for the treatment of cognitive deficits prevalent in SZ and provide a noninvasive tool to
monitor such treatment.

Public health relevance
Project Narrative This is a translational study that proposes to use a combination of newly developed magnetic resonance imaging measures and a promising neuroinflammation and oxidative stress-related blood biomarker (MMP-9) to test and validate those measures against a novel mechanistic model of schizophrenia. First, we will harmonize and use a large, already-collected multisite dataset to establish a relationship between neuroimaging, blood biomarkers and cognition, following which we will test the validity of this relationship in an animal model. Our research will vastly improve knowledge about the nature and biological specificity of neuroimaging biomarkers related to schizophrenia which will lead to development of new treatment and treatment monitoring strategies.